Modeling Therapy Sequence for Advanced Cancer: A Microsimulation Approach Using Real-World Data

Project Summary/Abstract
In modern treatment of advanced cancers, many patients go through multiple rounds of therapy using different
pharmaceutical agents. Although therapy switching is common in clinical practice, the cost-effectiveness of
sequences of therapies is under-studied. Effective and accurate modeling of multiple lines of therapy remains
an open problem. The often-used Markov model is memoryless, which is problematic when studying multiple
lines of therapy, as the model cannot easily deal with dependence within patients. Therefore, there is an unmet
and growing need to develop specialized models to evaluate the cost-effectiveness of therapy sequence (that
is, which agents are given and in what order). Real-world patient information extracted from the Electronic
Medical Record (EMR) provides a novel opportunity to better understand treatment outcomes in practice. We
can use EMR data to create improved health-state models which synthesize patient-level data, published
results from clinical trials, and health utility (quality of life) estimates from the literature. Here, we propose to
study therapy sequence by incorporating real-world data in microsimulation models. These state-transition
models use Monte Carlo methods to simulate individual paths through different health states. Our models will
particularly focus on correctly accounting for the dependence of events over time within patients. Patient-level
variables, such as tumor biology, age, and comorbid conditions, will impact treatment outcomes on all lines of
therapies, thus introducing statistical dependence. We will first estimate transition probabilities between states
using several parametric models fit to the EMR-based data. These transition probabilities will then be used in a
microsimulation model which also includes auxiliary information including healthcare costs and quality of life
adjustments (utilities). We will also develop a fully non-parametric approach using bootstrap resampling of the
patient population, where each individual’s path through model states will be used directly. Again, costs and
utilities will be incorporated for each health state. In simulation studies, we will assess the performance of each
model compared to a traditional Markov model approach. Finally, we will illustrate the application of this
method in a study of advanced urothelial carcinoma using an EMR-derived dataset created by Flatiron Health.
This dataset contains extensive data on treatments and outcomes including progression events and death,
however, it lacks all the measures we would need to conduct a full cost-effectiveness analysis (i.e. financial
costs and quality of life are not captured). We will demonstrate how our approach can be used to estimate the
cost-effectiveness of first-line carboplatin based therapy (vs. first-line cisplatin based therapy) followed by
second-line immune checkpoint inhibitors, and we will compare results from the different strategies.

Public health relevance
Project Narrative Cost-effectiveness of therapy sequence for advanced cancers is understudied, due to methodological challenges and the lack of datasets containing all necessary patient-level measures. We propose to develop a new approach using microsimulations which synthesize patient-level data derived from the Electronic Medical Record along with cost data, results from published trials, and quality of life measures. Our methods will enable researchers to study the cost-effectiveness of long-term treatment strategies, informing cancer patients, providers, policymakers, and payers.